A Multifaceted Radiomics Model to Predict Cervical Lymph Node Metastasis for Involved Nodal Radiation Therapy

A Multifaceted Radiomics Model to Predict Cervical Lymph Node Metastasis for Involved
Nodal Radiation Therapy
PROJECT SUMMARY
The majority of disease sites treated with radiation therapy (RT) no longer receive elective/prophylactic RT to
clinically-negative areas, including lung, pancreas, and lymphoma. These disease sites now employ involved
nodal radiotherapy (INRT), focusing on involved lymphadenopathy. However, in head and neck cancer (HNC),
we still target the same lymph node regions as conventional 2D radiotherapy, despite our ability to tailor the
radiotherapy volume and dose to specific areas using intensity modulated radiation therapy (IMRT). This
approach leads to excessive acute and long-term toxicities for HNC patients after RT. Therefore, INRT is highly
desirable for HNC. In INRT, one particular challenge during gross tumor volume (GTV) and clinical target volume
(CTV) delineation is the identification of malignant lymphadenopathy. While some lymph nodes (LNs) are
obviously malignant based on standard imaging modalities, there is often uncertainty about whether a LN is
malignant and requires targeting. Treating benign nodes as malignant may cause a significantly higher risk of
late complications, such as xerostomia and dysphagia. On the other hand, missing occult lymphadenopathy will
lead to regional recurrence. The goal of this project is to develop, optimize, and test a multifaceted predictive
model with both high sensitivity and specificity for LN metastasis classification to maximize the efficacy and
minimize the toxicity of INRT for HNC. The proposed multifaced model presents a flexible framework and
considers multiple aspects of a predictive model, including: 1) Evaluation criteria used in model training (multi-
objective); 2) Different sources of information (multi-modality); and 3) Classifiers used for model construction
(multi-classifier). By designing a multi-objective function, we will consider sensitivity and specificity
simultaneously during model training and optimization. Instead of blindly combining features extracted from
different modalities and empirically choosing one preferred classifier, the information extracted by modality-
specific classifiers will be combined optimally through a reliable classifier fusion (RCF) strategy. We will develop
a prospective registry database to train the multi-classifier, multi-objective and multi-modality (MCOM) model
through prospectively collecting clinical characteristics and images of HNC patients who will undergo surgery at
UTSW with pathology-confirmed LN metastasis status. The model will be validated on an independent UTSW
patient cohort and patients who underwent outside imaging but operated at UTSW. The specific aims of the
project are: 1) Develop and validate a multi-classifier, multi-objective and multi-modality (MCOM) LN metastasis
prediction model for HNC patients. 2) Conduct a randomized phase II clinical trial to evaluate the efficacy and
utility of INRT versus conventional radiotherapy for HNC using the MCOM model. Successful completion of this
project will result in the development and validation of a strategy that can identify malignant LNs in HNC with
high sensitivity and specificity, which will lead to improved outcomes for HNC patients who receive INRT.

Public health relevance
PROJECT NARRATIVE In definitive radiation therapy for head and neck cancer patients, there is often significant uncertainty about the malignant potential of cervical lymph nodes during treatment target identification. We will develop an advanced machine learning method through analyzing PET and CT images and patient clinical characteristics to accurately predict lymph node metastasis status. This tool will be deployed in a prospective randomized trial to show how strictly irradiating these identified lymph nodes, rather than the entire at-risk cervical neck, is oncologically sound and associated with improved quality-of-life.